Ultrasound-coupled Electrical Impedance Tomography for Sarcopenia Assessment

PROJECT SUMMARY/ABSTRACT
Clinical Need: The coming decades promise a revolution in the personalized treatment for patients with breast
cancer, including approaches to minimize collateral damage of curative. However, to help facilitate this, the
academic and industrial clinical research communities need improved diagnostic biomarkers to assess the
presence of muscle diseases such as sarcopenia. Once these diagnostic markers become available, these
tools will be needed to help to tailor therapy to the needs of individual patients. Limitations: Current
approaches for evaluating sarcopenia are very limited, with modest sensitivity and uncertain reliability. These
methods typically include simple force measurements, or imaging with MRI, CT or ultrasound (US). For
example, force measurements require patient cooperation making them very subject dependent with low
reliability. CT is considered the reference standard for assessing sarcopenia; however, it is not obtained in
patients with early-stage breast cancer. MRI is very expensive and not able to be performed in a routine clinic
visit. Finally, US is extremely convenient since it can be used directly in the clinic, however, it is qualitative and
very challenging to perform meaningful quantitative image assessment. Our Product – Ultrasound-coupled
Electrical Impedance Tomography (US-EIT) is an electrical property imaging device that integrates with a
standard ultrasound probe to provide augmented US imaging. Similar to Doppler imaging for blood flow
mapping, our device will be able to be ‘flipped on’ to provide a map of the electrical properties of the underlying
muscle tissue. Electrical properties of muscle have been shown by our group and others to be sensitive to
tissue properties reflecting muscle health, and has recently been found to be sensitive to inflammation;
however, this approach is a single local measurement and provides no spatial information regarding muscle
pathophysiology. We plan to combine for the first time ever in a commercial setting, electrical impedance
imaging with standard US for assessing sarcopenia. We hypothesize that this device will be sufficiently
sensitive and specific so as to provide a highly reliable output on muscle health. Specific Objectives: We
specifically propose to design a sonolucent electrode array and housing that seamlessly integrates to a
standard US probe. Secondly, we will evaluate our technology’s repeatability and ability to evaluate muscular
variability (i.e., distinguish levels of intramuscular fatty infiltration and inflammation) in a small feasibility trial in
pigs. Future Directions: RyTek Medical is a small company developing bioimpedance-sensing devices for a
variety of clinical applications. This device will complement our existing efforts. By the end of this Phase 1
effort, we will have demonstrated that the US-EIT probe is functional in an animal population, and we will have
provided evidence that this approach can distinguish quantify physiological markers of sarcopenia. This will
position us for Phase 2 funding focused on conducting a clinical trial aimed at assessing sarcopenia prior to
breast cancer treatment and preparing for a 510(k) or IDE application to the FDA.

Public health relevance
PROJECT NARRATIVE Many women with sarcopenia and curable early-stage breast cancer suffer collateral damage associated with chemotherapy-based toxicity, surgical complications, disease progression, and death of the treatment itself; unfortunately, limited cost-effective imaging and sensing tools exist to detect and quantify sarcopenia and therefore predict the potential harm of chemotherapy in women with early-stage breast cancer. We propose to couple a highly specific electrical impedance imaging modality to standard in-clinic ultrasound probes in order to improve diagnostic assessment metrics currently provided via US imaging; electrical impedance has been shown by our group and others to be sensitive to tissue properties reflecting muscle health, and has recently been found to be sensitive to inflammation– another factor associated with increased chemotoxicity and for the first time we propose to image these properties in tandem with US-based muscle imaging. This novel technology will provide highly specific spatial information regarding the heterogeneity of muscle and health in an easy-to-use bedside device that is directly coupled to standard ultrasound probes.